Isolation of bioactive proteins from natural product extracts

This project encompasses the PCMBS' efforts on isolation, characterization, sequencing, cloning, production in heterologous hosts, in vitro and in vivo evaluation of novel biologically active proteins from natural product extracts. Target extracts were initially selected for purification based upon either their activity in biochemical and cell-based assays for anti-cancer activity or their activity in inhibiting the infection of T-lymphoblastic cells by HIV-1RF. The majority of biological, three-dimensional structural elucidation, and clinical development studies are achieved through collaborations with researchers in the NCI, NIAID, CDC, DOD, commercial and non-profit licensees, and academic researchers. Specific Aim 1: Isolation, physical and biological characterization, cloning and heterologous expression of bioactive proteins derived from natural product extracts with activity against viral infections and cancer. Specific Aim 2: Identification of the molecular target(s) of antiviral or anticancer proteins, elucidation of their structure, mechanism of activity, and further testing of isolated, recombinant and modified proteins. Specific Aim 3: Preclinical and clinical evaluation of antiviral proteins such as griffithsin and its derivatives in pharmacokinetic, toxicity and efficacy studies in animal model systems (in collaboration with researchers in NCATS, CDC, commercial and non-profit licensees and academic researchers).